NKG2C+ Adaptive NK Cells For AML

We have established that allogeneic natural killer (NK) cell infusions have an anti-leukemic effect and induce
remission in 25-40% of patients with relapsed/refractory acute myelogenous leukemia (AML). Limitations include
effector cell persistence, activation, and specificity. Here, we will test novel approaches that address these
limitations. Our overarching hypothesis is that NKG2C+ adaptive NK cells given in a setting of “missing self”
will overcome suppressive mechanisms and mediate potent anti-AML activity and that targeting these cells with
immune engagers containing IL-15 will enhance their specificity to kill AML. Our group and others have explored
a population of cytomegalovirus (CMV)-induced adaptive NK cells expressing NKG2C and defined by a unique
methylation signature that is associated with superior inflammatory cytokine responses and antibody-dependent
cellular cytotoxicity (ADCC). These cells are also more resistant to regulatory T cells and myeloid-derived
suppressor cells. We completed a 1st generation trial to enrich for adaptive NK cells, but the frequency of NKG2C+
NK cells in the final product averaged <10%. We have now developed a 2nd generation process for expanding
NKG2C+ NK cells to generate a >80% NKG2C+ cells using HLA-E+ K562 feeders. In the current funding, we also
conducted first-in-human testing of IL-15 treatments. We developed our own IL-15-containing Tri-specific Killer
Engager (161533 TriKE) comprised of three functional domains: 1) an NK cell-engaging single chain variable
fragment (scFv) against CD16, 2) an AML-engaging scFv against CD33, and 3) an IL-15 linker between them.
We predict that the 161533 TriKE will target and activate endogenous NK cells to treat AML/MDS without
bystander T cell activation. We produced the 161533 TriKE under GMP conditions, cleared an IND, and started
clinical testing. However, NK cells are diminished in many cancers, and we believe that TriKE therapy might
ultimately prove most effective when combined with adoptive transfer of adaptive NK cells or other NK cell
products. Using adaptive NK cells as a model, we developed an off-the-shelf induced pluripotent stem cell
(iPSC)-derived NK cell product that expresses NKG2C/DAP12. When combined with an NKG2C TriKE, these
cells become antigen specific. We have developed themes in Project 1 that will inform the Program on whether
CMV-induced adaptive NK cells are optimal for cancer therapy, engage unique metabolic programs, can be
targeted with TriKEs, are more active in the setting of missing self, and can be mimicked in an off-the-shelf
strategy. Our Specific Aims are to 1) test a 2nd generation NKG2C+ adaptive cell product clinically in advanced
AML/MDS; 2) test a CD33-targeted, IL-15-containing TriKE in a phase I trial in patients with AML/MDS; and 3)
pre-clinically test the combination of the two in xenogeneic models and test whether our iPSC-derived NK cell
expressing NKG2C can be targeted with an NKG2C-specific TriKE. Results from these studies will inform Project
2 and 3 on the importance of NKG2C itself, optimization of targeting components within the TriKEs, and the
importance of missing self for clinical efficacy.

Public health relevance
We have discovered a unique population of NK cells that is primed to better attack cancer and can be targeted with immune engagers to enhance the specificity of NK cell-mediated killing. We will test the best way to use this knowledge in first-in-human clinical trials with the goal of making the treatment off-the-shelf for easy and feasible export to the cancer community. Clinical trials and pre-clinical investigation will test research themes that can be applied broadly against all cancer types.